Administrative Core

Project Summary -Administrative Core
The Administrative Core will provide the oversight necessary to first establish the Center in Transformative
Research in Metabolism at the University of Alaska during COBRE Phase I and then will ensure the long-term
sustainability of the center through all three COBRE Phases and beyond. Leadership of the Administrative
Core takes two forms: administrative and scientific. The Center Director, Dr. Kelly Drew, will lead administrative
components. Scientific leadership and professional advising is shared by the External Advisory Committee
members, the Translational Advisory Committee members, President's Professors and NIH-funded
advisors/collaborators. Dr. Drew is a nationally recognized leader in the study of hibernation and metabolism,
the scientific focus of the C-TRiM and has extensive administrative and mentoring experience. The External
Advisory Committee will assist Dr. Drew in C-TRiM-related oversight decisions and guide the Faculty
Development Plans that will enhance the ability of investigators to compete for complementary NIH individual
research grants or other equivalent extramural support, and ensure the longevity of the C-TRiM as a thematic,
multi-disciplinary, state-of-the-art research center in metabolism. The short- term goal for the Phase I COBRE
is to lay the foundation for achieving the long-term goal by implementing administrative oversight of the center,
executing the Faculty Development Plans for the C-TRiM Project Leaders, establishing productive and efficient
Core Facilities, overseeing a Pilot Project Program to seed the growth of junior faculty in the center and
providing critical evaluation of progress. To achieve the long-term and short-term goals of the C-TRiM, the
center leadership will pursue the following Specific Aims in the Administrative Core: SA1. Create a supportive
environment for the training and advising of basic and translational scientists. SA2. Establish two new technical
cores to support scientific goals of the Center. SA3. Define translational paths for basic science research in
mammalian hibernation SA4. Manage and administer the Pilot Project program. When complete the C-TRiM
will be the first biomedical research center in the US to adopt hibernation as a model of natural adaptations in
metabolism as an approach to solve complex clinical problems in the treatment of metabolic disease.